Identifying low dose measurement error corrected effects of multiple pollutants using causal modeling

Project Summary
The Candidate will contribute to the goals of the parent grant by using updated hybrid air pollution
exposure models and Medicare administrative data and link them with the newly acquired
National Death Index (NDI) data. The NDI data identifies the specific cause of death allowing the
Candidate to establish a complementary project that addresses the casual effect of air pollutants
with cause-specific cardiovascular mortality both individually and jointly within the Medicare
population. Specifically, the study will employ a quasi-experimental design (difference-in-
differences) that controls for both measured and many unmeasured confounders by stratifying on
either the subject (controlling for time invariant or slowly varying individual covariates) or the
neighborhood (controlling for time invariant or slowly varying neighborhood level covariates). This
is a major advantage of DID since many unmeasured and measured confounders are controlled
for by designed. We will employ updated exposure models for the years 2000-2020 with an
increased spatial resolution of 500m. By using a novel mixture technique, fast Bayesian Kernel
Machine Regression (BKMR), that accelerates the processing speed of the traditional BKMR, the
study can analyze big datasets such as Medicare. Fast BKMR identifies interactions between
individual pollutants, nonlinearities at low concentrations, and the overall effect of the mixture. We
will also produce estimates on a restricted subset of the Medicare population that lived in areas
that never exceeded the current EPA standards. This will help draw conclusions on whether the
current regulations are sufficient to protect cardiovascular health. With the support of this
supplement, we will incorporate the Candidate’s background in cardiovascular epidemiology and
mixture methods into our current Medicare study. Her proposed work for this supplement not only
aligns well with the objectives of the primary R01 but has the potential to contribute to the ongoing
efforts to tighten ambient air pollution regulations

Public health relevance
Project Narrative: The proposed supplement will study the causal effects of continuous air pollution exposure on cause-specific cardiovascular morality in the Medicare population and whether these effects are seen below the current regulations. The use of novel mixture and causal modeling methods will detect interactions, relative toxicity and dose response curves for the different pollutants and components. The training will help the Candidate develop the necessary skills needed to embark on an independent career as an environmental epidemiologist with a focus on causal methods and cardiovascular health outcomes.